The Military HIV Research Program ( MHRP ) Clinical Trial Unit

Abstract
COVID-19 Vaccine Clinical Development Team
The USG enterprise to develop and optimize vaccine prevention modalities for SARS CoV-2 incorporates
the DAIDS HVTN as a key partner in strategic development, research prioritization and execution,
landscape analysis for future directions and analysis of outcomes. Dr. Robb has co-chaired and
participated in the USG Vaccine Development Team for clinical research along with the PI and others
within the HVTN. The administrative amendment to CTU funding to HJF will sustain Dr. Robb’s role in
this capacity.

Public health relevance
Research Narrative COVID-19 Vaccine Clinical Development Team Dr. Robb will provide strategic advice to the NIH and other USG elements in efforts to develop and optimize the use of COVID-19 vaccines. This guidance is inclusive of preclinical, early clinical, and large scale fielding of effective vaccines. He will provide technical guidance to the COVPN leadership and specifically the HVTN, USG and other NIH funded networks on the testing of novel COVID-19 vaccines and monoclonal antibody countermeasures. Dr. Robb will participate in consultative COVID research advisory bodies to multiple USG and COVPN entities inclusive of NIH ACTIV, BARDA, DMID, CDC and NIAID Leadership Clinical Trial Networks. He will co-chair the Vaccine Clinical Development Team clinical group and their related meetings, participate in Product Coordinating Teams led by BARDA, participate in COVPN EMT and group meetings support all COVPN activities that are not already part of the scope of effort as a VTN CTU PI.